Methadone Loading Dose Initiation for Hospitalized Patients with Opioid Use Disorder Using Fentanyl

Project Summary/Abstract
Candidate: Ashish Thakrar, MD, MS, is an addiction medicine specialist, internal medicine physician, and
clinician-scientist committed to improving care for individuals with substance use disorders (SUDs). His career
goal is to become an independent investigator developing and adapting safe, effective, and patient-centered
pharmacotherapy for SUDs in the era of synthetic drugs.
Career Development Plan: To achieve this career goal, Dr. Thakrar will pursue coursework, seminars,
externships, and individualized instruction in four specific areas: (1) the behavioral pharmacology of addiction;
(2) responsible design and conduct of clinical trials for SUDs; (3) recruitment, assessment, and retention of
hospitalized patients for prospective research; and (4) qualitative and survey methods to assess patient
experiences in SUD treatment. These training goals are closely aligned with the research aims in this proposal.
Research Context: Each year, there are 500,000 medical or surgical hospitalizations for patients with opioid
use disorder (OUD), yet outcomes for these hospitalizations are poor: untreated withdrawal is common, patient
satisfaction is low, 11-17% of patients leave before medically advised, and less than 10% are discharged on
medications for OUD. While methadone at adequate doses treats opioid withdrawal, prevents before medically
advised discharges, and reduces mortality, there is little evidence on how to dose methadone to start treatment
for OUD with fentanyl use (“fentanyl OUD”). The traditional outpatient dosing approach to methadone initiation
does not consistently treat fentanyl withdrawal and takes weeks of titration to reach therapeutic doses. Given
methadone's long half-life, a “loading dose” approach could be a safe and effective alternative in the hospital.
Specific Aims: The goal of this proposal is to rigorously develop and pilot test a methadone loading dose
approach to starting treatment for fentanyl OUD in the hospital. Aim 1: To conduct a dose-finding study to
identify the maximum tolerated methadone loading dose appropriate for future study among persons with
fentanyl OUD. Aim 2: To conduct a randomized pilot trial of methadone loading dose initiation among
hospitalized patients with fentanyl OUD. Aim 2A is to assess trial feasibility, clinical outcomes, and safety; Aim
2B is to assess patient acceptability and other patient-centered outcomes with interviews and a survey.
Mentorship Team: Dr. Thakrar has assembled a team of mentors, advisors, and consultants with extensive
experience supervising research and with complementary expertise in behavioral pharmacology, clinical trials
of OUD pharmacotherapy, hospital-based prospective research, and patient-reported outcomes research.
Environment: The University of Pennsylvania and Penn Medicine offer an ideal environment to pursue this
training and research. Dr. Thakrar will succeed because of the support of an experienced and dedicated
mentorship team, outstanding research infrastructure, and extensive resources for professional development.

Public health relevance
PROJECT NARRATIVE General medical and surgical hospitalizations for persons with opioid use disorder (OUD) and fentanyl use are common, however patients often leave the hospital before completing treatment and without linkage to OUD care. This proposal seeks to take advantage of methadone's long half-life to develop a “loading dose” approach to starting methadone treatment for OUD and fentanyl use via a dose-finding study and a hospital- based randomized pilot trial. Findings will yield crucial insights into our understanding of methadone treatment, OUD with fentanyl use, and the design of hospital-based SUD trials, and could establish a new dosing paradigm for methadone treatment.